Neuroimaging Core

Core F: NIC Summary/Abstract
The overall goal of the PITT-ADRC is to perform and promote research that increases our
understanding of: 1) the etiology and pathogenesis of Alzheimer's disease (AD), 2) the mechanisms underlying
the cognitive and behavioral symptoms of AD, and 3) to develop strategies that will result in effective early
diagnoses and treatments for AD and related dementias. The Neuroimaging Core (NIC) will support these
Center-wide goals by developing and applying cutting edge neuroimaging technology to studies that are
focused on early and presymptomatic stages of the AD spectrum.
As the search for preclinical biomarkers continues, it is becoming increasingly clear that functional and
structural brain imaging data may hold the key to identifying the earliest pathological manifestations of AD prior
to any meaningful clinical change. The NIC will continue to develop and distribute technology for acquiring and
interpreting brain functional and structural imaging data in the support of AD research. The NIC will advance
the Center goals by supporting and promoting research that increases our understanding of the etiology and
pathogenesis of AD and facilitates the development of new therapies and methods for monitoring therapeutic
efficacy. The NIC maintains data sets of structural imaging on individuals enrolled through the Clinical Core,
and we continue to work on the expansion of leading-edge analytic technologies, and novel radiotracer ligands
measured with Positron Emission Tomography (PET) (i.e., PiB, AV-1451 and GTP-1).
The work of the NIC will accelerate efforts to identify early and presymptomatic AD by identifying
imaging biomarkers to monitor the natural and treated history of the disease. The curated, “trial-ready”
participant database will allow PITT-ADRC researchers to track biomarker-based clinical progression and to
identify risk and protective factors. This database will also uniquely position the PITT-ADRC to identify potential
participants based on specific biomarker characteristics. Finally, the NIC’s focus on quality assurance will
ensure that neuroimaging methods are generating data measuring what they purport to measure and that the
analysis stream retains the integrity of these data, ensuring that the statistical methodologies generate model
that are biologically meaningful.